Spatiotemporal control of RGS signaling

Abstract
G-protein Coupled Receptor (GPCR) signaling pathways are central to cell-cell
communication and cellular detection of the external environment. Conserved signaling
pathways are used to mediate such diverse processes as hormone signaling, immune function,
and cancer progression in humans and mating in yeast. Negative regulation of these pathways
by Regulators of G-protein Signaling (RGS) proteins is critical to maintaining cellular function in
the presence of continuous extracellular signal. The yeast RGS, Sst2, is cytosolic during
vegetative growth when the pheromone pathway is not active. Upon activation of the GPCR,
Ste2, the RGS binds to receptors at the center of polarized growth, but not the edges, and also
to septin structures that form at the base of the mating projection. The mechanisms that
regulate these interactions are not understood. We hypothesize that dynamic control of RGS
subcellular localization serves A) to enhance initial response to pheromone while maintaining
strong desensitization of the pathway later in the response, and B) to provide spatial regulation
of the pathway to enhance yeast mating. We will use live cell imaging, biochemistry, and yeast
genetics approaches to test this hypothesis. In aim 1, we will examine the effect of dynamic
RGS association with the receptor and septins and how these interaction impact sensitivity of
the pathway over time, morphogenesis, polarization, and mating. In aim 2, we will identify the
mechanism by which Sst2 interaction with the receptor and with septins are regulated. Dynamic
control of RGS-Receptor interactions is common in humans, and yeast provides an excellent
system to uncover the impacts this type of signaling motif has on cell physiology.

Public health relevance
Narrative The negative regulation of receptor signaling is important to prevent cancer and heart disease. We propose to use the yeast pheromone response as a model system for receptor signaling to understand how localization of the regulator of G-protein signaling (RGS) is changed over time and how that impacts the cellular response to extracellular signal.